Novel directions for investigating the role of VGF in comorbid Major Depressive Disorder and Alzheimer's disease

Late onset Alzheimer’s disease (LOAD), the most common form of dementia, and Major Depressive Disorder
(MDD) frequently co-exist, but the co-morbidity is not explained by common genetic variants. We have therefore
sought to identify shared pathophysiological mechanisms, and VGF is implicated in both AD and MDD. Several
AMP-AD groups exhaustively profiled gene expression in brain regions from multiple cohorts of AD and control
subjects, and then performed systems biology analyses which collectively identified VGF (acronymic) and its
network as a key driver (regulator) implicated in LOAD. Additional evidence supporting the relevance of VGF to
AD includes: 1) identification of reduced VGF levels in the brains and CSF of patients with neurodegenerative
disease including AD; 2) progressive decrease of VGF CSF levels with AD progression, suggesting its use as a
biomarker; 3) protective effect against the LOAD risk of an ApoE4 haplotype by high levels of VGF; and 4) our
data showing that hippocampal and cortical VGF levels are reduced in subjects with MDD, in mouse models of
depression-like behavior, and in the 5xFAD mouse AD model. Our preclinical studies show that 1) VGF
overexpression in 5xFAD hippocampus reduces cortical and hippocampal amyloid deposition, microgliosis,
astrogliosis, and cognitive impairment, and rescues neurogenesis deficits, and 2) chronic icv infusion of the VGF-
derived neuropeptides TLQP-21 or TLQP-62 (named by the N-terminal 4 amino acids and length) have similar
effects. As not all VGF activities are easily explained by its known receptors, we therefore identified additional
receptors and active members of the VGF network. Screening of a proprietary expression library identified TLQP-
21 binding to the neuropilins, NRP1 and NRP2, and TLQP-62 binding to the fibroblast growth factor receptor 2
(FGFR2). In Aim 1, we propose to better characterize these novel binding interactions biochemically and
computationally, and to determine their functional role(s) and downstream signaling, in vivo, in the APP/PS1 AD
mouse model, including in depression-like behavior. In vitro, we will assess their effects on microglial migration,
activation, and amyloid uptake. In Aim 2, to better understand VGF actions that may be transduced via its causal
network, which we constructed from AD and control subjects with and without MDD, we will investigate the role
in AD pathogenesis of the RAB3A interactor called rabphilin 3A (RPH3A), a key node in the VGF protein network
and regulator of neurotransmitter release and synaptic plasticity. VGF and RPH3A also share an association
with cognitive resilience in aged populations. We will assess the outcomes of RPH3A overexpression or ablation
on neuropathology, synaptic function, transcriptomics, and AD- and MDD-related behavioral phenotypes in the
APP/PS1 and the humanized hAbetaKI (LOAD) mouse models, to determine similarities and differences
between this nodal gene and VGF. In Aim 3, we will explore novel subnetworks and key drivers, comparing
expression in AD and AD+MDD brain, and cross-cell-type interaction networks that regulate neuron-microglial
VGF crosstalk. Our studies will elucidate new mechanisms and targets underlying comorbid AD and MDD.

Public health relevance
Narrative Comorbidity of Alzheimer’s disease (AD), the most common form of dementia, and Major Depressive Disorder (MDD) is frequent but unexplained by common genetic variants, with devastating public health impacts. To identify shared and unique pathophysiological mechanisms, we have utilized large-scale genomics and proteomics to identify critical regulators (drivers) in the signaling networks that contribute to pathogenesis and progression of AD and AD with comorbid MDD (AD+MDD). We propose to determine the underlying mechanisms by which VGF [a brain- derived growth factor (BDNF) inducible gene that regulates AD and MDD], VGF-derived neuropeptides and their novel receptors, and the VGF network driver RPH3A, regulate AD and AD+MDD, utilizing mouse models and bioinformatics approaches to determine the roles that these gene products play in disease pathogenesis and progression.